Preventing Infant Infections with Implementation Science in Malawi

Project Summary
Our program, “Preventing Infant Infection with Implementation Science in Malawi”, PRI3SM, will conduct 3
clinical studies to address incident maternal HIV infections during pregnancy and breastfeeding and
(re)engage pregnant and breastfeeding women with HIV frequently missed by traditional HIV care. Our
research projects will be supported by an Administrative Core, an Implementation Science Core and a Data
Science and Analytical Core. Our accumulated experience with EMTCT research in Malawi since 2002;
established local partnerships; cross disciplinary expertise in clinical research, epidemiology, implementation
and behavior science; and our synergistic projects put us in a superb position to impact MTCT by addressing
the following aims: Aim 1. (Research Program) Conduct 3 synergistic research projects focused on
addressing gaps in the EMTCT cascade that collectively expand HIV treatment and prevention in pregnancy
and postpartum to avert maternal and infant infections.Aim 1a. Project 1 (PrEP in Pregnancy) To evaluate
maternal and infant safety of PrEP regimens in pregnancy and breastfeeding. Cabotegravir (CAB)
injectable PrEP represents a substantial advance over daily oral PrEP7 and could dramatically reduce new
maternal infections. But CAB has not been systematically studied in pregnant and lactating women. We will
establish a national registry of CAB and TDF/FTC PrEP users who become pregnant alongside a safety cohort
of pregnant women receiving PrEP to compare pregnancy and infant outcomes. Aim 1b. Project 2
(Postpartum Prevention Package) To optimize post-partum HIV prevention including PrEP uptake and
persistence among at-risk lactating women to prevent primary HIV infection and subsequent infant infection
using a novel integrated task-shifting intervention strategy including partner engagement and testing, PrEP,
and community outreach. Aim 1c. Project 3 (PAC-Man) To evaluate reach and effectiveness of a novel
community-based service model, the “Point-of-care (POC) Active Case-finding & Management” (or
PAC-Man) model to identify and test infants missed through routine facility testing and determine
effectiveness and measure implementation outcomes including, adoption, implementation, sustainability, and
cost per pediatric HIV case identified. AIM 2. (Admin Core) Create a robust administrative structure to
implement and integrate research protocols efficiently and effectively, support the Implementation Science and
Data Science and Analytical Cores, and nurture existing rich partnerships with the sponsor, Ministry of Health
and HIV PEPFAR implementing partners. Aim 3. (Support Cores) To establish robust Implementation
Science and Data Science and Analytical Cores to provide support to the study projects, support Ministry of
Health program evaluation, and facilitate engagement of early-stage investigators through existing D43
capacity building programs. Broadly, we expect to identify successful implementation strategies with the
potential to achieve elimination of pediatric HIV in Malawi and beyond.

Public health relevance
Project Narrative The Preventing infant infections by Implementation Science in Malawi (PRI3SM) project will conduct 3 related studies addressing the main reasons for pediatric HIV infections in Malawi, supported by administrative, implementation science and data science and analytical cores. Project 1 and Project 2 focus on preventing new infections in Mothers during pregnancy and breastfeeding and Project 3 focuses on promptly testing infants born to mothers with potential higher risk to transmit based on missing key services. PRI3SM has potential to reduce pediatric infection in Malawi and may provide a successful model for other countries to follow.